Visualsonics Vevo 3100 Ultrasound Imaging

Abstract
Rodent animal models, including genetically engineered animals, surgical models, and naturally occurring
disease models, remain the cornerstone of preclinical research, and are routinely used to study the
mechanisms and pathogenesis of human disease and develop new therapies. High resolution ultrasound
imaging is an essential phenotyping tool to be able to study internal animal anatomy and physiology non-
invasively across the animal’s lifespan, during disease pathogenesis, and before or after preclinical testing of
treatments. This SIG application requests funds to purchase a Visualsonics Vevo3100 Ultrasound Imaging
System. This new imaging system will be essential to the operations of the Physiology Phenotyping Core,
which has almost two decades of experience in providing ultrasound imaging to NIH funded investigators
across the University of Michigan Campus. The new Vevo3100 will replace an aging Vevo 2100 that has
reached its end of supported lifespan and routinely requires costly repairs. The Vevo3100 utilizes very high
frequency linear array MX-series transducers that provide the highest resolution 2D and 3D imaging of small
animal heart structure and function available, and also allow for quantitative, functional imaging of blood
vessels and tumor volumes in animals as small as mouse embryos and up to large rats and rabbits. EKG and
respiration gating and EKV Software provide unparalleled cine loop image reconstruction during the cardiac
cycle at up to 10,000 frames per second, and enables a novel 4D Imaging Mode (3D + time) to capture 3D
imaging of the heart during the cardiac cycle at near MRI levels of resolution but at a fraction of the time and
cost. In addition, the VevoVasc imaging analysis and high-resolution color Doppler imaging provides a
capability of analyzing consequences of vascular disease including aneurysms, atherosclerosis and the
physiological effects of thrombosis. Importantly, the Vevo3100 will be incorporated into a robust, fully
functional animal phenotyping core with expert ultrasound technical staff, an efficient recharge mechanism,
standing animal protocols, procedural space, and laboratory animal support to ease access to novice or expert
users across the university. The core also provides users access to surgical models of cardiovascular disease,
telemetry recording, blood pressure, drug delivery and other phenotyping modalities which provide a pipeline
for preclinical studies from disease models to experimental outcomes. For example, when combined with the
blood pressure telemetry services available in the Physiology Phenotyping Core, VevoVasc allows for real-time
non-invasive analysis of vascular wall mechanics. Overall, the Vevo3100 will allow the Physiology
Phenotyping Core to provide new state of the art modes of functional ultrasound imaging to NIH funded users,
and by replacing aging end-of-life equipment will allow the core to continue to provide ultrasound services to
users into the next decade.

Public health relevance
Project Narrative Cardiovascular disease and cancer remain the top two causes of death and major contributors to worldwide disease burden and health care costs. Advances in high resolution ultrasound imaging have revolutionized the ways in which one can non-invasively examine the anatomical and physiological phenotypes in the most common animal models of human disease used in today’s biomedical research. This proposal requests funding for a new state of the art ultrasound imaging system that will enhance the research of numerous NIH funded investigators focused on small animal disease models and preclinical testing of new therapies in the areas of heart disease, vascular disease and cancer.